Centralized assay datasets for modelling support of small drug discovery organizations

Project Summary
Collaborations Pharmaceuticals, Inc. was formed after identifying a need for software to assist academics and
smaller companies in curating their data and discovery of new hits or lead optimisation. In the past two years the
continued importance of artificial intelligence (AI) is apparent from the explosive growth in number of these
companies and the increasing number of multi-million dollar deals with pharma using Machine Learning (ML) to
assist in drug discovery. There is a heavy focus by these companies on the drug discovery modeling aspect but
there is a continued unmet need and bottleneck in the curation of quality in vitro and in vivo data ADME/Tox data
for ML as well as prospective testing to validate the technologies. In Phase I, we developed a prototype of Assay
CentralÒ software and used this with a wide variety of structure activity data from sources both public and private,
formatted and unformatted, with ~14 collaborators working on neglected, rare or common disease targets as
well as used it for our internal drug discovery projects. In Phase I we also created error checking and correction
software. We also built and validated Bayesian models with the datasets that were collected and cleaned. And,
in addition, we developed new data visualization tools. The software can be used to create selections of these
models for sharing with collaborators as needed and for scoring new molecules and visualizing the multiple
outputs in various formats. In Phase II, we have developed Assay CentralÒ into a production tool which is easy
to deploy, built on industry standard technologies, provided graphical display of models and information on model
applicability. Importantly, we identified that customers wanted us to provide them with the results! We developed
our fee-for-service consulting services model using Assay CentralÒ to solve their problems and this has
expanded our revenues annually. In Phase II we evaluated additional ML algorithms and molecular descriptors
with manually curated datasets as well as compared algorithms across over 5000 auto-curated datasets from
ChEMBL. This illustrated the utility of access to multiple algorithms and how the Bayesian algorithm was
generally comparable to these other ML algorithms. This also motivated us to develop new software to integrate
these algorithms. We have also explored finding rare disease datasets and applying our data curation and ML
approach to them. With these and additional collaborations, as well as internal projects on Alzheimer’s disease
(through a NIH NIGMS supplement) we have been able to repurpose already approved drugs for several targets
for this and other diseases. For multiple projects we have performed several rounds of model building and fed
data back into the models to enable improved predictions. Finally, we have developed prototype tools to enable
us to develop automated molecule designs, assess their synthesizability and perform retrosynthetic analysis.
These combined efforts dramatically increased the number of projects we were able to work on (and ultimately
publish to raise our visibility), created new spin off products as collections of models (MegaTransÒ, MegaToxÒ
and MegaPredictÒ), molecule related IP, and generated employment. In Phase IIB we now propose a focus on
steps to aid commercialization and further development of these technologies. We have identified that
developing auto-curation software for dealing with complex biological data in unstructured databases will be a
competitive advantage. We have also recognized that for many diseases we can have a complete or near
complete collection of targets which may enable us to understand how a molecule may interfere with biological
pathways from structure alone and this can be applied to complex diseases and “adverse outcome pathways” in
toxicology. We also propose integrating state of the art multi-objective generative models for molecule design
into our Assay Central computational software in order to complement our analog generation and retrosynthesis
tools created in Phase II and aid in molecule optimization. We will validate this capability using some of the hit
molecules identified in Phase II for different targets including human acetylcholinesterase. Assay Central would
then have a full suite of integrated capabilities from data curation through to molecule design and retrosynthetic
analysis and will enable us to attract larger deals with companies.

Public health relevance
Narrative In Phase II Collaborations Pharmaceuticals Inc. developed Assay CentralÒ software, applied it to build thousands of models using public and private drug discovery and ADME/Tox datasets and identified that the Bayesian algorithm performs comparably to other more advanced Machine learning (ML) algorithms. We have applied this modeling approach to rare and common diseases to identify new molecules to test and have identified active molecules through numerous prospective validations, leading to many patents and publications. We have also applied the trademarked Assay CentralÒ technology on consulting projects with pharmaceutical, consumer product and preclinical CRO companies, demonstrating it meets an unmet need and in the process generated revenues. As we have developed software to propose novel compounds for testing, that integrates our machine learning, molecule design and retrosynthesis we now propose extending our auto-curation to unstructured databases, integrating machine learning models for a disease pathway and the addition of multi- objective generative models in order to build out our Assay Central capabilities.